A Multidimensional Aging Science Program: MSTEM Scholars Trained in Aging Research (MSTEM STAR)

PROJECT SUMMARY / ABSTRACT
In Medicine, Science, Technology, Engineering and Mathematics (MSTEM), there is a shortage of
underrepresented students (i.e., ethnic minorities, women, LGBTQ+, individuals with disabilities, first-
generation students, and those from low-income or otherwise disadvantaged backgrounds) who devote their
careers to issues that affect an aging population. California State University, Fullerton (CSUF), a Hispanic-
serving institution, proposes to implement a multidimensional aging science research education program titled
MSTEM Scholars Trained in Aging Research (MSTEM STAR). The goal of the MSTEM STAR program is to
increase diversity in the MSTEM aging research workforce by recruiting underrepresented MSTEM majors
interested in aging and helping them to develop the skills necessary to pursue the highest level of educational
attainment in their respective fields. The program has three specific aims. First, students will participate in
structured research experiences through one-on-one faculty research mentoring and an intensive summer
research experience at a local research-intensive (R1) university (i.e., UC Irvine, UCLA). Second, a student-
centered aging science curriculum will be developed, leading to a minor in Aging Studies, which will provide a
foundation in aging science, foster research skills, and promote an understanding of how the science of aging
relates to students’ lives. Finally, strong student support and engagement will be fostered by mentoring and
guiding students through extracurricular activities designed to improve professional skills and graduate school
preparedness. The MSTEM STAR program will include three two-year cohorts of six students each. Students
will be recruited as sophomores to participate in their junior and senior years. In addition to enrolling in aging-
science related coursework, students will be paired with MSTEM faculty research mentors at CSUF, and then
with an R1 research team for an intensive summer research experience following their junior year. A separate
support mentor will guide each cohort through skill-building activities and engagement opportunities with older
adults. Formal program evaluation efforts will be employed to track student success and to provide data for
future contributions to pedagogical best practices. Successful implementation and completion of this program
will increase the number of students from diverse backgrounds who are prepared for and successfully
undertake advanced degree programs in MSTEM fields related to aging. Research and education components
will be created with a focus on sustainability: The MSTEM STAR program is designed to endure beyond the life
of the grant, with the intent to continually prepare underrepresented students for graduate education in aging-
related MSTEM fields.

Public health relevance
PROJECT NARRATIVE There is a shortage of researchers from diverse backgrounds in Medicine, Science, Technology, Engineering, and Mathematics (MSTEM) who devote their careers to issues that affect an aging population. The MSTEM Scholars Trained in Aging Research (MSTEM STAR) program at California State University, Fullerton (CSUF) aims to address this shortage through the implementation of a multidimensional aging science program. Students enrolled in the MSTEM STAR program will complete structured research experiences, an aging- science curriculum, and support and engagement activities, which will prepare them to pursue advanced degrees in MSTEM fields related to aging.